The Interaction of Estradiol and Platelet Biology: A Mechanistic Exploration of Sex Dimorphisms in Coagulation

PROJECT SUMMARY/ABSTRACT
Dr. Julia Coleman is establishing herself as an early-career, translational surgeon-scientist with expertise in
trauma-induced coagulopathy (TIC), sex dimorphisms in platelet function, and their mechanistic underpinnings
to improve the care of injured patients. This K08 award will provide her with the support necessary to accomplish
the following goals: (1) become an expert surgeon-scientist in sex dimorphisms in platelet function as it relates
to TIC; (2) study the mechanisms underlying estradiol’s pro-platelet effect in vitro in donor platelets intended for
transfusion in bleeding trauma patients; and (3) develop the tools necessary to have an independent translational
research career. Dr. Coleman is supported by a multidisciplinary scientific advisory committee: primary mentor
Dr. Richard Gumina (Professor in Internal Medicine with expertise in purinergic biology and functional platelet
assays critical to this proposal); content co-mentors Dr. Thomas Hund (biochemist with expertise in calcium
signaling) and Dr. Bryce Kerlin (hematologist with expertise in thrombosis and hemostasis); scientific advisors
Dr. Kristy Townsend (neuroscientist with expertise in the effect of sex and estrogen on disease processes) and
Drs. Mitchell Cohen and Matthew Neal (translational surgeon-scientists with expertise in TIC and platelet
dysfunction). Trauma-induced coagulopathy, characterized by platelet dysfunction, is a leading cause of
preventable death despite decades of resuscitation practice optimization. An opportunity for advancement in TIC
treatment stems from an awareness that coagulation demonstrates a strong sex-dependent effect. Compared to
males, females have increased platelet reactivity, and in the setting of TIC, this results in decreased morbidity
and mortality. Platelets demonstrate sex-specific reactivity to P2Y receptor stimulation, which signals through
Src kinase. In addition to P2Y receptors, platelets also express estradiol-β receptors, and 17β-estradiol is known
to exert nongenomic effects on intracellular signaling pathways including Src kinase. As such, the objective of
this proposal is to test the central hypothesis that estrogen receptor-β stimulation on platelets primes Src kinase
signaling pathways to potentiate aggregation through nongenomic effects on P2Y receptors (Aim 1) and the
platelet proteome (Aim 2). To address these aims, we will perform a variety of platelet function assays in native
and estrogen-treated platelets in human apheresis platelets. Understanding these mechanisms at a basic level
is critical to advance translational studies to improve TIC-related morbidity and mortality for both sexes, as it may
impact donor sex-specific transfusion and support the use of estrogen-treated platelets in the resuscitation of
bleeding trauma patients. This proposal addresses a major gap in our understanding of the effect of biological
sex and estrogen on donor platelet biology. This will also generate data for an R01 application that translates
concepts from this platelet donor-focused project to platelet dysfunction in TIC to examine the role of recipient
sex and estrogen treatment in the blood of trauma patients.

Public health relevance
NARRATIVE This proposed research is relevant globally to public health because traumatic injury is one of the leading causes of death worldwide. Most early preventable deaths are due to uncontrolled bleeding and trauma- induced coagulopathy, which is defined by platelet dysfunction and distinct based on biological sex. Understanding sex-based differences in platelet function and the role of sex hormones in promoting clot formation is essential to impact how we resuscitate and transfuse injured patients to decrease trauma-related morbidity and mortality worldwide.